Investigating Transplacental Immune Pathways Contributing to Fetal Brain Pathology in Maternal Influenza

Project Summary/Abstract
The overarching goal of this application is to identify targetable transplacental immune signaling pathways for
optimizing antenatal therapies that improve maternal and offspring health outcomes during seasonal influenza
outbreaks. Influenza viruses pose ever-present threats to the health of pregnant women and escalate the risk of
neurodevelopmental disorders in their offspring. Yet, how and which immune signals propagate across the
maternal-fetal interface to impact fetal brain development during gestational influenza virus infection are
unknown. The objective of this proposal is to assess the extent to which transplacental immune signaling drives
fetal brain pathologies during maternal respiratory influenza virus infection. The central hypothesis is that
gestational influenza causes leukocyte and lymphocyte infiltration into the placenta and enhances transplacental
inflammation that is ultimately sensed by fetal microglia and border-associated macrophages, leading to
subsequent fetal brain pathologies. The premise for this proposal is that influenza-driven immune signaling must
cross the maternal-fetal interface before reaching the fetal brain. Surprisingly little is known about the contribution
of transplacental immune signaling in directing aberrant fetal brain development during gestational influenza
virus infection. This is significant because noninvasive antenatal therapies directed at curbing inflammation at
the maternal-fetal interface could mitigate fetal neuroinflammation and subsequent neurodevelopmental
disorders. The current proposal will use cutting-edge spatial transcriptomics to define time-dependent phenotypic
and functional shifts in immune and non-immune cells at the maternal-fetal interface during maternal respiratory
influenza infection. Rates of placental vascular permeability and leukocyte diapedesis as well as their
dependence upon IL-6 signaling will be defined throughout mid-to-late gestation. The extent to which fetal brain
microglia and macrophages shift their proliferation, activation, and colonization patterns in response to
transplacental IL-6 signaling will help determine whether this cytokine could be targeted in clinical settings.
Overall, these studies will illuminate transplacental immune mechanisms by which gestational influenza
predisposes individuals to neurodevelopmental disorders and will provide insights for mitigating fetal
neuroinflammation during related viral pandemics.

Public health relevance
Project Narrative Influenza virus infection during pregnancy is a leading risk factor for offspring neurodevelopmental disorders. This proposal will illuminate specific cellular and molecular mechanisms by which transplacental inflammation during maternal influenza virus infection directs fetal neuroimmune function and subsequent brain development trajectories. Our findings will provide evidence for or against the use of specific cytokine inhibitors as viable treatment options to protect both mother and fetus during infection with influenza viruses and/or related pandemic viruses.